Administrative Core

PROJECT SUMMARY/ABSTRACT – Administrative Core
The Administrative Core is responsible for establishing and maintaining the organizational structure that
provides effective managerial, scientific, and budgetary oversight for all aspects of the CCEH. This involves, in
part, establishing an Internal Advisory committee, and four Core-specific user committees composed primarily
of research base members and at least one non-member user. An External Advisory committee will be
described after the Coordinating Center comes on line. The Administrative Core will promote and ensure
communication among these groups, which will, in turn, serve to inform new initiatives and optimize core
development and utilization. Another key function of the Administrative Core is to provide guidance and
oversight for generating and using program income. Program income is used to increase core staffing and
supply budgets to meet growing user demand, and to introduce new technologies. Program income also
supports internal pilot awards and the Enrichment Program, both of which are implemented and overseen by
the Administrative Core. This Core also provides follow-up for all pilot awardees and for data generated with
CCEH support to ensure it is entered when appropriate into the publicly searchable data archive for annotated
data, techniques, and protocols currently under development for the purpose of data sharing.
The Administrative Core is led by Drs. Beverly Torok-Storb, CCEH Director and Derek Stirewalt, Associate
Director. Dr. Torok-Storb has successfully led the Fred Hutch CCEH and its Administrative Core from its
inception in 1999 as a P30-supported CCEH. Dr. Stirewalt seamlessly stepped in as Associate Director in
2017. Fifteen years of experience administering the CCEH have taught us that the Administrative Core will play
a critical role in all CCEH decision-making.